The Cleveland Digestive Diseases Research Core Center (DDRCC)

SUB-CORE SUMMARY The objective of the Cleveland DDRCC Mouse Models Core is to provide a comprehensive set of cost-effective services and shared resources to DDRCC investigators that augments their performance of in vivo studies focused on the pathogenesis of Digestive Inflammation/Tumorigenesis and Liver Disease/Metabolism. The overall goal of this Core is to provide centralized mouse modeling services that will enhance the pace of in vivo digestive disease-related research at Case Western Reserve University and the Cleveland Clinic Lerner Research Institute and provide communal, cost-effective access to unique mouse models on intestinal inflammation and liver disease, thus resulting in new research projects, funding opportunities, and collaborations in these areas of investigation. In support of the development of a germ-free (GF) and fecal material transplantation (FMT) sub-core, we are requesting an administrative supplement to expand this sub-core. We are proposing the following three Specific Aims: 1) Provide experimental cohorts of GF SAMP1/YitFc, Winnie, and TNFΔARE mice for experimentation; (2) performing fecal material transplantation (FMT) of gut microbiome into GF Mice; and (3) rederivation of unique mouse strains and their derivatives into GF mice. Thus, the GF and FMT sub-core benefits DDRCC members by providing a combination of uniquely available resources and cost- effective services that facilitate the development of research related to digestive diseases in the Cleveland scientific community and beyond.

Public health relevance
This attachment remains unchanged by supplemental request.